Anaplasma phagocytophilum exploitation of regulated exocytosis.

SUMMARY
Regulated exocytosis is a conserved eukaryotic process that is essential for numerous cellular functions,
making it a prime target for exploitation by both infectious and non-infectious diseases. Indeed, various
malignancies, viruses, bacteria, and protozoa commandeer this pathway to promote disease progression.
Numerous studies have interrogated the molecular players of regulated exocytosis that are modulated in
cancer formation, including the conserved second messengers, calcium (Ca2+) and sphingosine-1-phosphate
(S1P). However, far less is known about the mechanisms that intracellular bacterial pathogens employ to
exploit this process. Human granulocytic anaplasmosis is an emergent disease caused by the obligate
intracellular vacuolar-adapted bacterium, Anaplasma phagocytophilum (Ap). Ap is a tick-transmitted pathogen
that exhibits an unusual tropism for neutrophils. A primary function of neutrophils is to destroy microorganisms
through degranulation, a form of regulated exocytosis. Intriguingly, both Ap-infected neutrophils and ticks
exhibit prolonged degranulation and increased exocytosis, respectively. We recently published that the Ap-
containing vacuole (ApV) resembles a host multivesicular body (an organelle that undergoes regulated
exocytosis) and that late-stage ApVs mobilize to and fuse with the plasma membrane to release Ap into
extracellular milieu for reinfection. Our preliminary results indicate that intracellular Ca2+ concentration ([Ca2+]i),
sphingosine kinase 1 (SK1 [produces S1P]), and S1P are increased late in Ap infection and that inhibition of Ap
protein synthesis prevents these phenomena as well as ApV exocytosis. These data suggest that Ap
manipulates regulated exocytosis for egress. We also uncovered a potential mechanistic role for the Ap
effector, P130, in this process. P130 is upregulated during late Ap infection and localizes to the cytosolic face
of the ApV membrane. We discovered that P130 interacts with host calcium and integrin-binding protein 1
(CIB1), which, to date, has been indirectly implicated in regulated exocytosis. CIB1 also localizes with P130 on
exocytosing ApVs, further supporting its role in Ap dissemination. In Aim 1, we will interrogate the relevance of
[Ca2+]i and S1P to ApV exocytosis and infectious progeny release using in vitro and in vivo approaches. In Aim
2, we will identify the P130 domains necessary for its interaction with CIB1 and its promotion of ApV exocytosis
as well as determine the relevance of CIB1 to ApV exocytosis in vitro and in vivo. This work will advance our
fundamental understanding of the mechanisms that intracellular bacterial pathogens utilize to facilitate their
release and potentially define novel roles for CIB1 in host cell biology and infectious disease.

Public health relevance
PROJECT NARRATIVE The intracellular bacterium, Anaplasma phagocytophilum, causes the potentially fatal human infection, granulocytic anaplasmosis. This proposal will dissect how A. phagocytophilum exits host cells using a process known as regulated exocytosis as an essential step in disease progression. As numerous other pathogens and malignancies commandeer regulated exocytosis, the fundamental knowledge generated by this project could lead to novel therapeutic targets for treating diverse diseases.